Investigational New Drug Development of Noribogaine for Alcohol Use Disorder

ABSTRACT
DemeRx NB is a Miami-based clinical stage drug development company advancing noribogaine for the treatment
for alcohol use disorder (AUD), based on accumulated knowledge of the drug’s pharmacology, toxicology and
its potential clinical utility. Therapeutic agents for AUD have not progressed, and relapse rates in patients are
high. Noribogaine hydrochloride is a new chemical entity azepinoindole that fits into a category of novel
“psychoplastogen” therapeutic agents. Chronic exposure to alcohol sensitizes the reward system to alcohol-
related cues, interferes with the processing of non-drug reward, increases impulsivity, and disrupts emotional
regulation. There is a current shift in therapeutic strategy for complex brain disorders to focus less on rectifying
single target “chemical imbalances” and more towards selective modulation of neural circuits. Noribogaine
interacts with two or more CNS targets simultaneously and the drug has demonstrated predictive validity in
animal models of AUD. Radioligand binding assays, nonclinical animal studies, and Phase 1 data from placebo-
controlled trials of noribogaine do not suggest psychotropic effects or a potential for abuse. Noribogaine
hydrochloride is a stable molecule that undergoes limited metabolic degradation in vitro. Cytochrome P450
inhibition studies indicate a low probability of drug-drug interactions. DemeRx NB has developed a scalable and
reproducible GMP manufacturing process and characterized the crystalline ansolvate of noribogaine. Company
milestones include development of assays/analytical methods for product characterization and release (potency,
purity) and early stage in vitro and in vivo toxicology studies. Clinical pharmacokinetic studies have also been
conducted in healthy volunteers and opioid dependent subjects, and safety have been characterized. DemeRx
NB requests SBIR/STTR support for IND-enabling nonclinical studies including subchronic repeat dose toxicity
studies and an EEG/EMG/EKG study, that are necessary to advance noribogaine to Phase 2 efficacy trials for
AUD.

Public health relevance
NARRATIVE Alcohol use disorder (AUD) is a chronic disorder that impacts 16.1 million people in the US, posing a significant challenge to individuals, their families, employers, and the economy. This SBIR project plans to conduct animal studies to advance noribogaine as a new medicine with no mind-altering effect or dependence potential for the treatment of AUD. The animal studies will provide important insights into the safety of the drug on the path to FDA approval. This new information will guide dose selection of noribogaine for clinical trials in patients who are unable to stop or control alcohol use despite adverse occupational or health consequences.